FDA-VET-LIRN Grant

Rollin-Vet-LIRN:
2024 Studies on Antimicrobial Resistance in Bacterial of Veterinary Importance
Project Summary
The North Carolina Veterinary Diagnostic Laboratory System is a full-service multidisciplinary veterinary
diagnostic laboratory. The NCVDLS received over 46,000 client accessions in 2023. Our diagnostic
laboratory is uniquely situated to screen for and research existing and emerging microbial pathogens of
agricultural and companion animal importance given the prominence of animal agriculture (poultry and swine
production) in our state and continual urban/suburban growth. The Bacteriology section services our main
laboratory and our three branch laboratories. Along with bacteriology submissions from clients they process
high volumes of in-house samples from necropsy. The bacteriology laboratory has MALDI-TOF and available
BSL3 workspace. The Bacteriology laboratory has performed over 13,000 tests in the year 2023 on clinical
samples, tissue, serum, bacterial isolates, and environmental samples. The NCVDLS hopes to partner with the
FDA and play an active role in pet food and animal feed contamination investigations:
1) Participation in VPO designated sample analyses and surveillance activities to promote animal health
and welfare and add to the Vet-LIRN Network’s surge capacity to assist in emergency and large-scale
outbreak testing.
2) Provide analytical data to support regulatory actions by developing and using standardized methods,
equipment platforms, and reporting methods, continued participation in proficiency testing provided by
the VPO, continue investigating consumer reported cases as requested by the VPO, and continuing to
improve and implement standardized quality management systems as designated by the VPO.
3) Participate in small-scale antibiotic susceptibility testing studies by sharing bacterial isolates to address
emerging antimicrobial resistance issues, and participate in AMR surveillance.
The bacteriology section of the NCVDLS hopes to engage in cooperative activities with the FDA Vet-LIRN, the
Vet-LIRN network, and federal, state, local and tribal organizations to promote animal health and feed and food
safety and security.

Public health relevance
Rollins-Vet-LIRN 2024: Studies on Antimicrobial Resistance in Bacteria of Veterinary Importance Project Narrative Today, emergence of antibiotic resistant bacteria is considered as a global threat. Prudent susceptibility testing and use of antibiotics will help us to reduce the antibiotic resistance burden. The NCVDLS Bacteriology laboratory wishes to engage in cooperative agreement opportunities with the FDA Vet-LIRN and the Vet-LIRN network of veterinary diagnostic laboratories to promote the areas of food and feed surveillance, antibiotic susceptibility testing, quality management, promote animal health and feed and food safety and security and provide surge capacity for large-scale testing in the event of an emergency.